Meeting Support for the Cognition and Medical Image Perception Think Tank. POP 4/29/19 - 10/13/19.

Support to the NCI by the Scientific Consulting Group for Meeting Support for the Cognition and Medical Image Perception Think Tank